Identification of Prodromal Neurodegeneration in Serotonergic-Induced REM sleep Behavior Disorder

Abstract
The majority of Dementia with Lewy bodies (DLB) patients have a clinical syndrome of dream enactment that
typically develops years before the onset of cognitive impairment. Under normal physiological conditions, rapid
eye movement (REM) sleep is characterized by vivid dream mentation combined with skeletal muscle atonia.
This REM paralysis is lost in REM sleep Behavior Disorder (RBD), resulting in patients who trash, punch and
kick at night. RBD is a common condition affecting 80 million people worldwide and >5% of those older than
70. The presence of RBD is highly indicative of underlying neurodegeneration as nearly 75% will develop a
neurodegenerative disorder in 12 years, most commonly DLB or other disorder of alpha-synuclein pathology
such as Parkinson's disease (PD). Among patients with RBD approximately half have developed, or have had
exacerbated, their dream enactment after starting a serotonergic antidepressant (usually a selective serotonin
reuptake inhibitor-SSRI). This emergence of dream enactment after starting an SSRI, is termed serotonergic
RBD (5-HT RBD) and was until recently assumed to be caused by a toxic effect on REM sleep circuitry.
However, careful scrutiny of patients with 5-HT RBD reveals neurodegenerative findings suggestive of
impending DLB, such as impaired color vision, mild cognitive impairment and subclinical motor deficits. These
insights suggest that SSRI antidepressants do not induce RBD but instead unmask RBD in an individual who is
already burdened by early alpha-synuclein pathology. However, this has not been proven, and it remains
critical to understand whether 5-HT RBD is, as we suspect, an indicator of prodromal Lewy-body type
pathology. This project will test the hypotheses that people with 5-HT RBD have systemic alpha-synuclein
pathology, brainstem lesions in regions that control REM sleep, and prodromal DLB signs. AIM 1 will seek to
detect abnormally phosphorylated alpha-synuclein aggregates on skin biopsy in a cohort of people with 5-HT
RBD and matched controls (taking SSRIs but without RBD). Aim 2 will use ultra-high field MRI at 7T to
examine the pontine region of the coeruleus/subcoeruleus complex for evidence of neurodegeneration as well
as segment and parcellate REM sleep related neuronal structures. Aim 3 will test for prodromal deficits in
speech consistent with Lewy body disease. While these Aims are independent we suspect that the severity of
speech deficits will correlate with loss of neuromelanin signal on MRI and pathology on skin biopsy. These
studies are important because confirming neurodegeneration in 5-HT RBD would be a breakthrough in
understanding the natural history and progression of DLB pathology. Most importantly, by identifying an early
prodromal syndrome and biomarkers of disease progression, this project will help speed up the development of
therapies to impede or prevent the progression of Lewy body pathology.

Public health relevance
Project Narrative It is uncertain whether serotonergic REM sleep Behavior Disorder (5-HT RBD), like isolated RBD, is a prodromal syndrome of Dementia with Lewy bodies. This project will test for the presence of abnormally phosphorylated alpha-synuclein aggregates on targeted skin biopsy in 5-HT RBD compared to matched controls. Additionally, we will prospectively explore for brainstem neurodegeneration, segment and parcellate pontine regions that control REM sleep as well as evaluate for speech deficits consistent with Lewy body pathology.